National Drug Early Warning System Coordinating Center

PROJECT SUMMARY/ABSTRACT
Our team enthusiastically submits this proposal to be the next NDEWS Coordinating Center (CC) in response
to RFA DA-20-016. The CC is spearheaded by the Cottler Lab (Epidemiology), with investigators from
University of Florida's Center for Addiction Research & Education (Nixon, Goldberger, Striley), the Palamar
Lab at New York University and the Machine Perception and Cognitive Robotics Lab-Barenholtz) at Florida
Atlantic University. Our CC will maintain strong sentinel surveillance efforts while expanding our Early Warning
Network sites, adding leading edge indicators that extend beyond lagged city-level data. We will extend the
work of NIDA-funded researchers, while harmonizing and analyzing data, with timely and systematic
notifications. The new NDEWS CC will work to seamlessly transition on-going efforts, advance methods and
approaches, establish and engage a Scientific Advisory Group (SAG), and collaborate with all consortium
components to accomplish these Specific Aims: 1) Provide an Early Warning Network of 12 NDEWS sites and
6 Community Epidemiology Workgroup sites for ongoing surveillance of urban, rural, and suburban areas; 2)
Utilize established and new key community-level indicators for ongoing surveillance to assess trends in
availability, use, and consequences of NPS and known substances, standardized across all sites to facilitate
cross-site analyses; 3) Incorporate and leverage novel surveillance methods to ensure early detection of
signals of NPS and emerging drug trends, including data from DanceSafe “drug checkers,” Rapid Street
Reporting (RSR) with hair testing for NPS exposure, the implementation of a virtual HealthStreet substance
user network, and development of an innovative machine learning approach to detect emergence of NPS in
real-time through drug retailers (including the “darknet”) and social media platforms; 4) Harmonize
standardized indicator definitions for all incoming surveillance data with the input of NIDA, the SAG, and Early
Warning Network experts; facilitate cross-site comparability of data; manage quality control; organize,
coordinate, and summarize data, and provide organizational and logistical support; 5) Disseminate findings
quickly via dashboards modeled after Florida Drug-related Outcomes Surveillance and Tracking System
(FROST); push notifications for regular updates and alerts; webinars; virtual Our Community Our Health Town
Hall meetings; and traditionally through official reports, peer-reviewed publications, media, and annual
reporting at CPDD, and elsewhere; 6) Conduct on-the-ground epidemiologic investigations on topics of
immediate crisis or need; 7) Provide operational, administrative, and logistical support to the enterprise and
NIDA; and 8) Train the next generation of scientists in NDEWS methodology.
NDEWS has unrealized potential, and with this funding, we will transform the culture so that NDEWS is
NIDA's and the field's go-to source for drug trends in the US. It will provide evidence-based prevention and
intervention strategies to eventually reduce the harmful effects of substance use around the world.

Public health relevance
PROJECT NARRATIVE There is nothing more aligned with the NIDA Strategic Plan to protect the public health than detecting signals of emerging drug use trends. This proposal coordinates the data collection efforts from 18 sites and NIDA funded investigators to notify people everywhere of the signals detected. With this information, immediate responses can take place for interventions. The team at UF/NYU and FAU are strong and have the capability to immediately innovate an expanded National Drug Early Warning Network for the public health.